Mechanism Of Action And Functions Of The Gli-related Proteins Glis 1-3

Glis1-3 are novel genes identified in our laboratory. The Glis1-3 genes encode Kruppel-like zinc finger proteins containing five tandem zinc finger motifs that exhibit highest homology with those of members of the Gli and Zic subfamilies of Kruppel-like zinc finger proteins. In addition, the zinc finger domain of Glis1 and -3 exhibit high homology with that of Drosophila gleeful/lame duck suggesting that it may be the Drosophila homologue of Glis1 and -3. Glis3 is highly expressed in pancreatic beta cells where it regulates insulin gene transcription by binding to Glis-binding sites in the insulin promoter. In addition, Glis3 regulates pancreatic polypeptide expression in pancreatic PP cells. During pancreatic development Glis3 is expressed as early as in the bipotent pancreatic progenitors and remains expressed in pancreatic ducts and endocrine progenitors. When endocrine progenitors differentiate into the different endocrine lineages, Glis3 remains expressed in the beta and PP cells, but is repressed in glucagon, somatostatin and ghrelin producing cells. Glis3 deficiency leads to the development of neonatal diabetes, due to reduced insulin gene expression and in the number of pancreatic beta cells. Glis3 plays a critical role in the transcriptional regulation of insulin in pancreatic beta cells by recruiting CBP/p300, which may serve as a scaffold for the formation of a larger transcriptional regulatory complex containing Pdx1, NeuroD1, and MafA at the insulin promoter. Yeast two-hybrid analysis and mass spectrometry identified several Glis3-interacting proteins, including several HECT-ubiquitin ligases. We showed that Itch interacts with Glis3 and enhances Glis3 ubiquitination thereby reducing the stability of Glis3 protein and Glis3-mediated transcriptional activation. Glis3 is also expressed in the collecting ducts of the kidney and loss of Glis3 leads to polycystic kidney disease. In addition, Glis3 plays a critical role in spermatogenesis. It is expressed in spermatogonial stem cells and becomes down-regulated when these cells differentiate into differentiated spermatogonia. Mice deficient in Glis3 are deficient in mature spermatozoa and therefore infertile. Glis1-3 are expressed in a temporal and spatial manner during development. Glis3 is also critical in the synthesis of thyroid hormone in that Glis3 deficiency results in hypothyroidism due to a greatly reduced thyroid hormone production. Glis3 is essential for thyroid hormone biosynthesis and thyroid follicular cell proliferation. Under iodide-deficiency conditions Glis3 knockout mice do not develop goiter in contrast to wild type mice. These studies have demonstrated that Glis3 has a critical function in several tissues and plays a role in a number of pathologies Glis2 is highly expressed in kidney. To obtain insight into the physiological functions of Glis2, mice deficient in Glis2 were generated. Glis2 deficient mice develop a chronic kidney disease, nephronophthisis, that is accompanied by renal atrophy, fibrosis and inflammation. Ultimately Glis2 deficient mice die prematurely of renal failure. A large number of genes involved in immune responses/inflammation and fibrosis/tissue remodeling are induced in kidneys of Glis2 deficient mice. results in renal failure. Our study indicates that Glis2 plays a critical role in the maintenance of normal kidney functions. Glis3: Glis3 plays a critical role in pancreatic development and has been implicated in a syndrome with neonatal diabetes and hypothyroidism (NDH). Our study demonstrates that dysfunction of Glis3 leads to development of cystic renal disease suggesting that Glis3 plays a critical role in maintaining normal renal functions. Glis1 knockout mice develop proptosis that is related to increased intraocular pressure characteristic of glaucoma.